Function and regulation of cytoplasmic p53

ABSTRACT
While the principal function of tumor suppressor p53 is a nuclear transcription regulator that transcribes a
diverse set of genes involved in apoptosis, cell cycle regulation, and numerous other processes,
compelling evidences have also unraveled extra-nuclear, transcription-independent activities of p53 in
the cytoplasm, where it induces apoptosis and inhibits autophagy. However, significant gaps exist in the
knowledge of p53 in the cytoplasm. The lack of knowledge is due at least in part to the fact that
approaches investigating cytoplasmic p53 have been primarily in vitro studies in artificial settings.
Dissection of the mechanistic aspects of cytoplasmic p53 in an in vivo system is necessary to clarify the
biological events by which cytoplasmic p53 exerts its extra-nuclear, transcription-independent functions.
Recent genome sequencing analyses of bats discovered many unexpected variances between bats and
other mammals. Among them are the bat-specific alterations in the nuclear localization signal (NLS)
sequences in p53. The alterations are predicted to hamper bat p53 nuclear import, resulting in increased
cytoplasmic accumulation. To explore the significance of cytoplasmic p53, we generated mice
expressing a mutant p53 that has an altered NLS sequence to mimic bat p53 NLS. We identified that p53
interacts with lactate dehydrogenase B (LDHB), which plays a critical role in lipid metabolism. We also
found that cytoplasmic p53 promotes autophagy through disrupting Beclin 1-Bcl-2/Bcl-xL interaction and
activating Beclin 1. IP-mass spectrometry experiments using cytoplasm-sequestered p53 and identified
CUL9, a cytoplasmic cullin RING E3 ubiquitin ligase, as a major p53 binding partner. Biochemical
experiments revealed that CUL9 catalyzes K63-linked, non-proteolytic polyubiquitination of p53. In this
proposal, we test the hypothesis that cytoplasmic p53 exerts tumor suppression and anti-aging functions
through inhibiting glycolysis, increasing lipogenesis, and promoting autophagy. Such functions of p53 are
regulated by CUL9 catalyzed, K63-linked p53 polyubiquitination.

Public health relevance
PROJECT NARRATIVE The overarching goal of this application is to understand the p53 tumor suppression network for the purpose of improving human disease diagnosis and treatment. The proposed researches will provide new insights into the biological function and regulatory mechanism of p53 in anti-tumor and anti-aging processes. The study will facilitate our knowledge of the fundamental regulatory mechanisms for p53, and will potentially lead to the development of therapeutic strategies for the treatment of human diseases.